NATIONAL RISK FACTOR SURVEY ON OSTEOPOROSIS

The purpose of this study is to determine the reproducibility of measurements of the amount of bone mass on our new Quantitative Digital Radiography (QDR) Bone Densitometer.